Multi-disciplinary analysis of the role of PagC for outer membrane vesicle biogenesis

PROJECT SUMMARY/ABSTRACT
Bacterial outer membrane vesicles (OMVs) are small, spherical protrusions composed of the inner and outer
leaflets of the Gram-negative outer membrane. OMV diameters typically range from 20 to 200 nanometers (nm),
although the mean size varies widely across species. Biogenesis of these vesicles requires induction of positive
membrane curvature at a point of origin, after which expansion and subsequent scission of these vesicles
proceed in an ATP-independent manner. Functionally, OMVs are primarily produced as response elements to
environmental stresses, including large temperature shifts, pH perturbation, and divalent cation limitation.
Despite numerous studies supporting the biological significance of OMVs, the underlying mechanisms of
biogenesis remain elusive. In Salmonella enterica subsp Typhymurium (STm), recent evidence suggests that
PagC, a product of the PhoPQ regulon, is sufficient to induce vesiculation when produced during low pH and
divalent cation conditions. PagC is an eight-stranded ß-barrel that spans the outer membrane with four
extracellular loops (EL1-4), two of which (EL2 and EL3) are reported as critical drivers of PagC-mediated OMV
biogenesis. In vivo experiments guided by molecular dynamic simulations identified several key residues that
may mediate a conformational change that induces positive membrane curvature required for OMV production.
Accordingly, we hypothesize that PagC induces OMV biogenesis by introducing positive membrane
curvature through conformational shifts in extracellular loops 2 and 3. Using an integrative approach of
biophysical, biochemical, ultrastructural, and microbiological techniques, we will define the molecular
underpinnings of PagC-mediated OMV biogenesis. As outlined in Aim 1, we will leverage solid-state nuclear
magnetic resonance to monitor the dynamics of PagC in a native OMV environment. Using a combination of
solid-state nuclear magnetic resonance and proteomics as described in Aim 2, we will define interactions of
PagC with outer membrane components to clarify the physical requirements for enhancement of OMV production
by PagC. Finally, we will use the proposed experimentation in Aim 3 to optimize studies for screening the
phenotypic consequences of wild-type and mutant PagC isoforms. Taken together, our studies will utilize an
integrative approach to describe the mechanisms of PagC-mediate. Although the extracellular loops of PagC
appear to be unique to STm, we expect that the induction of membrane curvature through a protein
conformational shift may provide a framework for studies in other bacteria. Given the challenges of high-
throughput screening for key factors involved in OMV biogenesis, our studies may provide a basis for mining
OMV proteomic studies to identify candidate outer membrane proteins that facilitate OMV production in other
bacterial species.

Public health relevance
PROJECT NARRATIVE The expression of PagC during the Salmonella infectious cycle results in a robust increase in outer membrane vesicle biogenesis, which is a process that is essential to infectivity. However, the lack of enzymatic activity of PagC suggests an underlying physical mechanism for induction of the membrane curvature required for outer membrane vesicles production. Our investigations will define the physical requirements that license PagC to induce outer membrane vesicle biogenesis, thus contributing to our understanding of a critical aspect of Salmonella infectivity and virulence.